PROJECT 1: IMPACT OF DIFFERENT E-CIGARETTE CHARACTERISTICS ON ACUTE LUNG INJURY

PROJECT SUMMARY/ABSTRACT
Over the past decade, use of electronic cigarettes (e-cigarettes) has been rapidly growing. Because e-
cigarettes are relatively new to the market, there is little biologic data on their health effects, particularly how
these health effects are affected by specific product characteristics. Experimental evidence can identify early
signals of harm associated with e-cigarettes, but several important elements have been largely missing from
prior studies, including (1) an assessment of pulmonary health effects after clinically relevant insults, like acute
viral or bacterial infection; (2) an integrated assessment of acute pulmonary effects across cell culture, animal,
and human models; and (3) a focus on specific device and e-liquid characteristics that are subject to regulation
and might be modified to reduce adverse health effects. The UCSF TCORS has extensive experience studying
the impact of tobacco products on acute lung injury using laboratory and human experimental models, and our
preliminary data indicate that variation in e-cigarette characteristics may have a significant impact on
pulmonary health. This project proposes a comprehensive assessment of the impact of varying e-cigarette
characteristics on acute lung injury, combining data from cell culture, mouse models, and human subjects. The
central hypothesis is that changes in e-cigarette device and liquid characteristics influence their acute
pulmonary effects, both under healthy conditions and in the setting of acute respiratory infection and/or
inflammation. This hypothesis will be tested via two specific aims: (1) Test how different device characteristics
(applied power and metal coil components) impact the acute pulmonary effects of e-cigarettes, including
susceptibility to viral or bacterial lung injury in cell culture and in mice, and to inhaled endotoxin in human
subjects (e-cigarette users and dual users); and (2) Test how different e-liquid characteristics (nicotine
concentration and flavorings) impact the acute pulmonary effects of e-cigarettes, including susceptibility to viral
and bacterial lung injury in cell culture and in mice, and to inhaled endotoxin in human subjects (e-cigarette
users and dual users). Both aims begin with a systematic evaluation of the impact of varying e-cigarette
characteristics in cell culture and mouse models. This evaluation will be conducted with and without infectious
and inflammatory stimuli, including viral (influenza) and bacterial (pneumococcal) infection. The e-cigarette
characteristics that appear to be most important in these models will then be tested in a well-established
human experimental model of lung injury, in which healthy volunteers inhale endotoxin, followed by
bronchoscopy with bronchoalveolar lavage. This project contributes to the overall UCSF TCORS theme by
focusing on the acute pulmonary health effects of specific e-cigarette device and e-liquid characteristics.
These studies will yield important new knowledge regarding how specific e-cigarette device and e-liquid
characteristics impact their potential to cause acute lung injury, both in a state of health and in the setting of
acute infectious or inflammatory stimuli, which will inform regulation of product characteristics.